Remmie.ai a deep learning diagnostic engine for ear-nose throat disease

PROJECT SUMMARY
Otitis Media (OM), commonly referred to as an ear infection, is the most common reason for antibiotics use in
children under 6 years of age. OM is also the second-most common cause of hearing loss globally, impacting
1.4 billion individuals in 2017 and currently ranked as the fifth highest disease burden. Otitis media with
effusion (OME) is a condition characterized by the presence of fluid behind the eardrum, often causing hearing
difficulties, while acute otitis media (AOM) refers to a sudden and painful infection of the middle ear, commonly
associated with fever and earache. Perforated eardrum and tympanosclerosis can result from untreated OM,
and these conditions can lead to hearing loss and other complications when left untreated. To prevent
unnecessary and harmful delays to OM diagnosis and management, there is a significant need for widespread,
affordable, and convenient access to otolaryngology specialists. OM is an ideal candidate for real-time
telemedicine visits due to its defined symptoms and visual diagnosis that can be accomplished with
straightforward data points and imaging. However, no platform currently exists to facilitate effective virtual visits
for ear infections. The overall goal of this Phase II project is to further develop and validate Remmie.ai, a next-
generation ear-nose-throat (ENT) mobile health platform, as an innovative telemedicine solution for accurate
and efficient diagnosis of OM. The three aims outlined in this proposal converge to empower Remmie.ai as a
transformative force in healthcare. Aim 1 leverages extensive image and data collection efforts to further refine
Remmie.ai models, enabling precise classification of OM. Aim 2 orchestrates real-world clinical testing to
validate Remmie.ai's effectiveness, assessing its impact on diagnoses and patient care in both in-person and
telemedicine settings. Finally, Aim 3 charts a path towards FDA designation by fortifying the platform's
infrastructure for data privacy and security, ensuring regulatory compliance, and refining the user-friendly
Remmie App. Together, these aims harmonize data-driven AI enhancements, clinical validation, and regulatory
groundwork, propelling Remmie.ai towards its overarching goal of democratizing access to otolaryngology
expertise and improving the diagnosis and management of ENT conditions while safeguarding patient privacy
and adhering to regulatory standards.

Public health relevance
PROJECT NARRATIVE The Remmie.ai project seeks to address the pressing issue of Otitis Media with effusion (OME), Acute Otitis Media (AOM), Otitis media with effusion (OME) is a condition characterized by the presence of fluid behind the eardrum, perforated eardrum, and tympanosclerosis, which are common causes of infection in children and can contribute to hearing loss. To bridge the gap in timely diagnosis and management, this Phase II initiative aims to refine Remmie.ai, an advanced telemedicine platform, for accurate ENT diagnosis support. Through expanding AI models, conducting real-world testing, and building a regulatory-compliant cloud infrastructure and app, Remmie.ai strives to develop accessible, high-quality healthcare solutions and contribute to improved ENT condition care.